The role of collisions in rescuing stalled ribosomes in bacteria

PROJECT SUMMARY
Translating ribosomes often encounter obstacles that stop them in their tracks. Ribosome quality
control (RQC) pathways remove stalled ribosomes from mRNA so that they can be recycled. In the
absence of RQC, bacteria are hypersensitive to many clinically important antibiotics that target the
ribosome. The goal of this proposal is to determine molecular mechanisms of RQC in bacteria. In the last
funding cycle, we established a new paradigm for how RQC factors in bacteria selectively recognize
stalled ribosomes. When a trailing ribosome collides with a stalled ribosome, a unique interface forms
between them, as revealed in cryo-EM structures of collided disomes from E. coli and B. subtilis solved
in collaboration with Roland Beckmann. In E. coli, SmrB binds between collided disomes and cleaves the
mRNA, targeting it for degradation. Any trailing ribosomes on the truncated mRNA are quickly rescued
by the well-characterized tmRNA pathway. In B. subtilis, the SmrB homolog MutS2 lacks nuclease activity
and instead uses ATP hydrolysis to split stalled ribosomes into subunits. Here we address three questions
raised by our discovery that ribosome collisions trigger these two different RQC pathways in E. coli and
B. subtilis. First, what advantage does splitting ribosomes into subunits have compared to rescuing them
with tmRNA? We hypothesize that splitting is particularly important when ribosomes are inhibited by
antibiotics, given that the tmRNA pathway requires active translation. In Aim 1, we will determine how E.
coli cells split stalled ribosomes, building on our preliminary data identifying a novel RQC factor with
ATPase activity. We will characterize this protein biochemically and observe its activity in vivo with
ribosome profiling. Second, why does SmrB cleave mRNA in E. coli whereas MutS2 in B. subtilis does
not? Our preliminary data suggest that mRNAs lacking a stop codon are rapidly decayed in E. coli but
not in B. subtilis. Using sequencing approaches, in Aim 2 we will compare the effects of RQC factors on
the transcriptome in E. coli and B. subtilis. In addition, we will use selective ribosome profiling to identify
endogenous substrates for SmrB. Finally, ribosome collisions in eukaryotes lead to the activation of
signaling pathways. Are there also regulatory events that take place on collided disomes in bacteria? In
disome structures, the bL9 protein from the lead ribosome reaches back and contacts the trailing
ribosome. By preventing the trailing ribosome from binding EFG and attempting translocation, bL9 may
prevent frameshifting. In E. coli, bL9 is phosphorylated at sites that contact the trailing ribosome; we will
test whether phosphorylation of bL9 changes its activity, if phosphorylation changes under various
conditions, and identify the kinase responsible. These experiments will delineate molecular mechanisms
of RQC pathways that rescue stalled ribosomes in bacteria.

Public health relevance
PROJECT NARRATIVE Many antibiotics inhibit protein synthesis in bacteria by interfering with the function of ribosomes. The proposed studies will increase our understanding of how bacterial cells sense that problems have occurred during protein synthesis and will reveal the mechanisms by which they resolve these problems.